Dissecting the role of the dentate gyrus microcircuit to improve cognitive discrimination in aging and Alzheimer's Disease

The dentate gyrus subregion of the hippocampus (DG) has been proposed to play a critical role in ‘pattern
separation’, a computational process by which similar experiences are transformed into discrete non-
overlapping neural representations. Deficits in pattern separation are found in normal aging as well as in Mild
Cognitive Impairment (MCI) and Alzheimer’s disease (AD). The dentate gyrus is one of only two brain regions
where new neurons are produced throughout life in mammals, a phenomenon termed adult hippocampal
neurogenesis (AHN). AHN has been shown to decrease markedly both in normal aging and in AD. We have
shown that AHN in mice is required for ‘cognitive discrimination’, a form of learning that may involve pattern
separation. In addition, our preliminary results show that a genetic and a pharmacological manipulation that
significantly increase AHN (iBax mice and Bax antagonist) rescues cognitive discrimination in aged mice.
However, due to technical limitations, our knowledge about the specific role of AHN in the regulation of
memory functions and how these processes are altered during age-related cognitive decline remain extremely
limited. We will leverage unprecedented genetic access to AHN in combination with recent technical
breakthroughs for neural recordings and manipulations to uncover the impact of AHN in aged mice. We will
test the hypotheses that abGCs support sparse memory encoding enabling effective pattern separation and
that increasing AHN can rescue age-related deficits in cognitive discrimination through improved pattern
separation. In addition to unraveling the function of AHN we will also explore whether this process can be
harnessed pharmacologically to rescue cognitive deficits associated with aging. We will test this in mouse
models of aging by leveraging the complementary expertise of the Hen lab in targeted molecular and
pharmacological manipulations of AHN in behaving mice, the expertise of the Losonczy lab with in vivo large-
scale optical recordings, and the expertise of the Fusi lab in computational modeling approaches. At the end of
the grant period, our experiments will have provided transformative new insights into the function of abGCs
and into the therapeutic potential of targeting AHN to alleviate age-related cognitive deficits in normal aging
and possibly in age-related disorders such as MCI and AD.

Public health relevance
Aging is the major risk factor for Alzheimer’s disease (AD) and Mild Cognitive Impairment (MCI). Recent evidence indicates that adult hippocampal neurogenesis is reduced in normal aging as well as in MCI and AD, and could therefore be an effective target of therapies for age-related cognitive decline. However, the specific role of adult hippocampal neurogenesis in the regulation of memory functions and how these processes are altered during aging remain unknown. In this project we will employ recent technical breakthroughs in genetic and pharmacological targeting of adult hippocampal neurogenesis in combination with cutting-edge physiological recordings and computational simulations to provide transformative new insights into the function of adult hippocampal neurogenesis and into the therapeutic potential of targeting this process to alleviate age- related cognitive deficits in normal aging as well as in age-related disorders such as MCI and AD.